The Effect of Value-based Payment on Heart Failure Quality of Care (Value-HF)

PROJECT SUMMARY/ABSTRACT
Heart failure causes over 80,000 deaths and $30 billion in spending annually, yet therapies that improve
survival and reduce morbidity are underutilized. Insufficient healthcare quality and high costs sparked the
development of value-based payment programs, such as Medicare’s Merit-based Incentive Program (MIPS).
MIPS is the largest clinician value-based payment program in use in the United States. MIPS is intended to
improve the quality of care while reducing costs by altering clinician payments based on clinician performance
on cost and quality measures. MIPS quality measurement is increasing its focus on patient-reported outcome
(PRO) measures, including for heart failure, despite limited evidence that PROs improve heart failure care. Aim
1 will be a pragmatic, single-center randomized trial evaluating whether integration of PRO assessment into
the routine heart failure clinic workflow is feasible and improves health-related quality of life at one year. This
patient-oriented trial will determine if the clinical impact of PRO assessment is worth the costs of data
collection. Aim 2 will evaluate the association between the introduction of MIPS (in 2017) and trends in
Medicare heart failure care: guideline-recommended therapy use, mortality, and costs. This study will use
multiple analytic approaches and controls (VA and commercially insured heart failure patients) to develop
robust estimates of these associations. This work will have a substantial impact on heart failure clinical care
and patient outcomes by defining the effect of both routine PRO assessment and MIPS as a whole. It will
inform the design of future clinician value-based payment models. Dr. Sandhu will use this research along with
the protected time, training, and mentorship of this K23 Award to become an independent, patient-oriented
health services researcher. Dr. Sandhu’s long-term research goals are to improve the quality and efficiency of
heart failure patient care by evaluating the implementation of local quality improvement and national health
policy. The proposed research experience and the training in clinical trials and causal inference statistics
during this award is critical to achieving those goals. He will gain these skills through coursework, local
research seminars, national conferences, and direct instruction from his mentorship team. His mentors are
experts in implementation trials, outcomes analysis, and advanced statistical methods. They are supplemented
with an exceptional advisory committee with complementary expertise in clinical trials, heart failure, and health
policy. With this mentorship team and support from the Stanford Department of Medicine, Dr. Sandhu will have
the tools to efficiently complete the trial in Aim 1. His rigorous training plan, the expertise of his mentors, and
his experience with the data make the sophisticated policy analysis in Aim 2 feasible. Overall, the training,
research, and mentorship of this award will guide Dr. Sandhu in his transition to becoming an independent,
successful patient-oriented health services researcher with the skills to compete for R-level funding.

Public health relevance
PROJECT NARRATIVE Medicare’s Merit-based Incentive Payment System (MIPS) is a value-based payment model designed to improve healthcare value by adjusting clinician payments based on cost and quality measures, including recently introduced patient-reported outcome measures. This study aims to evaluate the impact of MIPS on heart failure care by determining the effect of routine patient-reported outcome assessment on heart failure quality of life, and evaluating the association between MIPS and heart failure therapy patterns, mortality and cost. These findings will impact heart failure treatment and patient outcomes by guiding policy-makers in the design of future value-based payment models.